Research Education

SUMMARY / ABSTRACT
The overall goal of the Boston OAIC REC is to train future independent research scientists who have
the knowledge and skills to translate fundamental mechanisms of disease and disability into novel
interventions that can improve the health, physical function, and well-being of people as they age.
The REC will achieve this by selecting the most promising early career (Pre-K Award) scientists from
clinical and basic science disciplines, and providing them with both collective and individual
educational activities, research experiences, mentoring, and career guidance that will enable them to
acquire future career development or research awards and ultimately become leaders in translational
research devoted to the discovery of function promoting therapies (FPTs). The REC’s specific aims
are as follows:
1. To select at least 6 talented early investigators from diverse clinical and basic science disciplines
who have strong potential to become independent investigators devoted to translational research.
2. To provide these trainees with two-year mentored research experiences focused on the
development of function-promoting therapies for people as they age.
3. To enhance the education of these trainees in relevant curricular areas through research seminars
and lectures, formal coursework, and specific training in the importance of diversity in science and the
protection of human and/or animal subjects.
By the completion of the proposed 5-year funding period, we will have selected and trained at least 6
promising new investigators in the field of aging. These early stage investigators will acquire the
necessary data, research experience, and mentorship to generate and test new hypotheses
regarding FPTs and compete successfully for independent funding for their future research. These
individuals will enrich the nation’s workforce with future leaders who will continue to develop new
interventions to promote physical function in old age and also train future generations of investigators
to continue vital work on this important theme.